GENETIC STUDIES OF CRANIOFACIAL DISORDERS

Determine genetic factors involved in human craniofacial development. Specific aim is to evaluate the clinical phenotype of patients with craniofacial disorders.